Development of a Piezoelectric Intramedullary Nail for Enhanced Fracture Healing

PROJECT SUMMARY
The objective of this Phase I SBIR is to develop a modular piezoelectric intramedullary nail for enhance
fracture healing and post-operative data collection. Evoke Medical’s core technology is to create human-
powered implantable devices that utilize piezoelectric materials to generate load-induced power. That power can
then be used for various purposes: electrical stimulation of bone growth and/or load-sensing to track healing
progression. Through former SBIR Phase I and Phase II support, we have successfully developed and
manufactured a fully integrated piezoelectric spinal fusion implant. The embedded piezogenerator and
miniaturized circuitry convert patient motion to mechanically synced electronegative stimulation delivered to the
healing site via external titanium electrodes. Through two ovine studies, it has been proven that these load
induced osteoinductive spinal fusion implants stimulate faster and better spinal fusion without pathologic bone
formation. Utilizing this platform technology, a preliminary design concept for a novel modular piezoelectric
intramedullary (IM) nail has been demonstrated and a mechanically sound method of manufacturing efficient
piezoelectric implants with embedded circuitry was developed. Evoke Medical has formed strategic partnerships
that will allow us to design, build and test piezoelectric IM nail implants that can eventually be manufactured in
volume at a reasonable cost.
Intramedullary nails are the preferred and most widely used treatment for femoral fractures in the US. Despite
reported generally good outcomes, fracture nonunion is a chronic medical condition that creates costly and
severe consequences for patients, physicians, and the medical system at large. In general, 5-15 percent of
fracture fixation patients for all bone fractures in the USA develop some form of compromised union. Some
fracture types and patient populations have a larger number of reported nonunion rates as high as 54 percent,
resulting in over 100,000 fractures progressing to nonunion annually. The rate of healing can be slow in all
patients, especially in tobacco users and patients with diabetes. Tobacco users have been shown to have ≥1.6x
greater risk for nonunion than those who do not use tobacco and people with diabetes have been shown to have
a ≥6x greater risk for malunion. Implantable direct current (DC) electrical stimulation has over 30+ year clinical
history of enhancing bone healing but need for an implanted battery and challenging form factors have limited
widespread use. The premise of the Phase I proposal is that a modular IM nail implant with integrated load
induced DC stimulation will promote a faster and more robust fracture union in comparison to the current
standard of care.
The overall goal of this Phase I is to de-risk the piezoelectric modular IM nail design concept, from both
a worst-case mechanical strength and electrical output perspective. Specifically, we will prove that the
power output from a custom ring piezogenerator design integrated with the other novel IM nail implant
components can produce sufficient electrical stimulation under the physiological loading in expected clinical
settings (low frequency and limited weight bearing). Additionally, we will assess from a mechanical design
standpoint that the assembled implant can withstand worst case biomechanical loading and clinical use loading
scenarios (e.g., bending and impact). The outcome of a successful effort will be a verified IM nail prototype with
integrated piezogenerator that can be carried into a Phase II effort to prove safety and efficacy of the
mechanically synced electrical stimulation in an ovine study.
The results of this work will set the stage for Phase II funding to integrate and miniaturize the circuit and electrode
components into the IM nail design and proceed with the verification and validation testing needed for regulatory
evaluation. As part of the future Phase II work, we will investigate the addition of sensing circuitry to track healing
progression and complete in vivo validation ovine studies to justify moving forward with commercialization.
Following, additional funding will be raised to complete early clinical trials required for expanded regulatory
claims around enhancement of fracture healing and diagnosis of successful outcomes. The target IM nail market
is over $658M with a compound annual growth rate of 4.7%. The proposed device is hypothesized to increase
success of healing and decrease time to heal, as well as give patients and healthcare providers quantitative
outcome measures without expensive CT scans or biased patient self-reporting. This would decrease overall
cost of care and human suffering, as earlier, data driven post-operative decisions could be made, preventing
nonunion and additional revision surgeries.

Public health relevance
PROJECT NARRATIVE Femur fracture fixation is one of the most common orthopedic procedures. Of the 235,000 operable fractures of these longs bones each year in the USA, about five to ten percent will not heal, resulting in nonunions and/or malunions, or will have delayed healing. It has been reported that femoral nonunion has a severe debilitating effect on patient health and wellbeing and is incredibly costly to the healthcare system and society due to the loss of work and quality of life. This problem is especially bad for patients who have risk factors such as diabetes or tobacco use. Tobacco users have been shown to have ≥1.6x greater risk for nonunion than those who do not use tobacco and people with diabetes have been shown to have a ≥6x greater risk for malunion. The poor healing problems with lower extremities are especially problematic for our Wounded Warfighters injured by IED explosions. The Evoke Medical solution will provide a non-pharmacological, cost-effective way to create intramedullary nail implants that will provide bone healing electrical stimulation as well as post-operative healing monitoring from a human’s body motion. Our platform technology generates Mechanically Synced Electrical Stimulation (MSES) to help these patients heal better and faster, with each step they take. Utilizing human powered technology, this implant can provide therapeutic bone healing stimulation right to the fracture site and signal to the physician the healing progression for earlier intervention; all without a battery or external brace relying on patient compliance. Our long bone fracture fixation device will give surgeons a way to enhance their patient care, while simultaneously reducing cost of care and improving patient outcomes.